Towards Interpretable Imaging-based Gastric Cancer Prognosis via Prototypical and Attentional Deep Learning

ABSTRACT
The main goal of our project is to develop innovative interpretable deep learning models for multi-modality
imaging in cancer prognostic assessment. Overall, we aim to improve both the accuracy and the interpretability
of prognosis decisions from deep learning models. On the one hand, accurate prognostic assessment plays a
key role in personalized treatment. Gastric cancer prognosis has historically been determined based on tumor
histopathology (i.e., size, grade, etc.) and TNM staging. However, the current clinical staging system cannot
accurately predict the prognosis of gastric cancer, and patients in the same stage would have significant
variability in treatment outcomes. Therefore, it is crucial to develop new approaches for accurate prognostic
prediction of gastric cancer patients on an individual basis. With the rising of artificial intelligence (AI), deep
learning models show enormous potential in cancer prognosis tasks. On the other hand, nevertheless, only
limited deep learning models have been adopted in clinical settings, primarily due to their lack of transparency
and interpretability, which makes it challenging to gain the trust from doctors as well as patients especially for
the high-stake scenarios such as prognosis and treatment decision-making. Existing deep learning models are
mostly black-box and fully data-driven in nature, without integrating domain knowledge from physician experts
and/or disease pathobiology. Thus, constructing interpretable deep learning models is also of great importance
in gastric cancer prognosis, to better enhance the patient's treatment outcomes and life quality. Computed
tomography (CT) and hematoxylin & eosin (H&E) stained whole-slide pathological images (WSIs) are
commonly used in the clinical examination of gastric cancer patients. Our prior research has demonstrated that
both CT and WSI images contain valuable prognostic information for gastric cancer and validated that deep
learning approaches are effective for analyzing these types of images. To bridge the research gaps in
interpretable prediction with deep learning, distinct from previous work, we will integrate domain knowledge
from physician experts with biological insights into the model inference process through prototypical and
attentional modeling, which are informed by and designed to capture important aspects of disease
pathobiology. We propose three aims specifically: AIM1) Build a knowledge-guided Vision Transformer (ViT)
that employs informative visual prototypes for explainable prognosis on CT images; AIM2) Develop a
knowledge-guided Graph Neural Network (GNN) that employs contributive subgraph prototypes for
interpretable prediction based on singe-cell classification; AIM3) Design a novel attentional multi-modal
learning approach to fuse the clinical attribute information together with the complex interactions between WSI
and CT in latent spaces for transparent prognosis. If successful, the proposed methods will enhance the
accuracy and interpretation of prognosis predictions. Considering that CT and H&E imaging is used as part of
routine clinical care, our study could provide new tools to improve treatment decisions, without additional cost.

Public health relevance
NARRATIVE It is currently estimated that up to around 30% of patients diagnosed with gastric cancer are over- or under- treated, sustaining substantial morbidities from unnecessary side-effects or treatment failures. Our proposal focuses on developing innovative deep learning methods with intrinsic interpretability to analyze radiology and pathology images, enhancing the model's generalizability and clinical applicability, while providing valuable information to complement the current clinical staging system. Ultimately, effectively integrating radiology and pathology imaging with the current clinicopathological markers could enable more informed, precision- medicine, treatment decisions to reduce unnecessary side-effects while improving long-term outcomes for patients diagnosed with gastric cancer.